Integrative and Quantitative Biosciences Accelerated Training Environment

Abstract
The InQuBATE T32 at the Georgia Institute of Technology will support the integrated training of
interdisciplinary Ph.D. students advancing the integrative study of living systems enabled by high-
dimensional data analytics and computational models. Student-driven discoveries will broaden
the knowledge-base of living systems to address foundational challenges of biomedical relevance
spanning molecules, cells, to populations (whether in biofilms amongst population of microbes or
between eukaryotic cellular assemblages from tumor microenvironments to cardiac tissue). T32
trainees and affiliates will learn to reason quantitatively about living systems given uncertainty,
implement rigorous data analytic principles and algorithms as computational software, extract
information and insights from high-dimensional bioscience data sets, and communicate the
relevance of their findings to advancing basic research and industrial applications. Outreach will
focus on junior- and senior-level undergraduates at local and national institutions as a means to
enhance the pipeline of diverse students entering interdisciplinary bioscience Ph.D.-s. The
translation of core discoveries into industrial and translation applications will be facilitated by
industry engagement events where trainees will acquire practical management and leadership
skills, applied data analytics training, and will expand their professional networks via direct
interactions with industry leaders via multiple industry partners. Overall, the InQuBATE T32 will
transform the core set of competencies of Ph.D. students across the spectrum of bioscience,
bioengineering, and data science disciplines. In doing so, the T32 program will integrate best
practices from bioscience, computing, and engineering disciplines, train the next generation of
biomedical scientists to harness the data revolution, and enable trainees to initiate dynamic
careers aimed at understanding the structure and dynamics of living systems and their impacts
on human health and well-being.

Public health relevance
Public Health Relevance Statement The InQuBATE T32 at the Georgia Institute of Technology will train PhD candidates spanning the biosciences, engineering, and computing to integrate computational models, data analytics, and the experimental study of molecules, cells, and populations. By fostering a quantitative and data-driven mindset, the T32 will train the next generation of thought leaders to identify principles underlying transitions between health and disease in complex living systems spanning microbial communities, developmental pathways, tumor microenvironments and the dynamics of tissue. Overall, InQuBATE will help transform the foundational and applied study of computational- and data-intensive biosciences in the 21st century and prepare diverse trainees for impactful careers across academia and industry.